Fatty acids-mediated inflammation and ethnic disparity in pregnancy outcome

DESCRIPTION (provided by applicant): African American women are at markedly increased risk for several adverse pregnancy outcomes including preterm delivery. These ethnic differences are not explained by known risk factors or by genetic variation suggesting that other factors contribute. Chronic low-grade vascular inflammation is an underlying mechanism for many health problems including the initiation, progression and thrombotic complication of atherosclerosis. Metabolic disturbances in lipids, glucose and insulin resistance trigger vascular inflammatory processes. Elevated levels of circulating free fatty acids (FFAs) and individual FFAs that are related to the amount and type of fat in the diet alter the inflammatory response. However, maternal FFAs-mediated inflammation and its influence on the ethnic disparity in adverse pregnancy outcomes have not been studied. The purpose of this study is to examine existing data from an ethnically diverse group of pregnant women to determine whether (i) maternal circulating FFAs and their proportional composition correlate to dietary fat intake and alter the inflammatory response; (ii) there are ethnic differences in the biomarkers of inflammation; (iii) ethnic differences in inflammation give rise to ethnic differences in preterm delivery and a serious complication of pregnancy (preeclampsia) that increase risk of later metabolic disease. The primary outcome to be examined is preterm delivery (<37 weeks gestation); the secondary outcome is preeclampsia. Markers of inflammation will include TNF-α, IL-1, IL-6, IL-8, C-reactive protein, fibrinogen, soluble TNF- receptors 1 and 2 and adiponectin. We hypothesized that low-grade vascular inflammation, as indicated by the markers of inflammation (MOI), is an independent contributor to the ethnic differences in preterm delivery and preeclampsia. Vascular inflammation is altered by circulating free fatty acids which are related to dietary fat intake. Because not all FFAs have the same effect on the inflammatory process, we will identify which fatty acids suppress (protective) inflammation and what fatty acids induce inflammation. The study will utilize existing data and biological specimens which were longitudinally collected from a large prospectively designed cohort study in Camden, New Jersey (N=2,816). The cohort includes healthy low income pregnant women from 3 ethnic groups (African American, Hispanic (mostly ~85% Puerto Rican) and White). The project will have a significant impact on understanding ethnic disparities in pregnancy outcome. Because circulating FFAs are well correlated with dietary fat/FAs intake, modification in the type or amount of fat in the diet will alter circulating FFAs levels, likely reducing vascular inflammation and potentially decreasing the ethnic disparity in poor outcomes. Thus, our data will provide an intriguing insight into racial/ethnic differences in amount and type of fat in the diet, in fatty aid metabolism and in inflammation as contributors to preterm delivery and preeclampsia which increases risk of metabolic disorders in later life.

Public health relevance
PUBLIC HEALTH RELEVANCE: Preterm delivery is a leading cause of infant morbidity and mortality. African-Americans are disproportionately impacted and the reasons are not fully understood. Circulating fatty acids are good indicators of dietary fat intake. Dietary change in the type of foods that are eaten or the way traditional foods are prepared will lead to differences in circulating levels of specific FFAs, which may, in turn, reduce vascular inflammation and modify the ethnic disparity in preterm delivery and preeclampsia both of which are related to the increased risk of later chronic disease. __SpecificAimsTextDelimiter__ Specific Aims The rate of preterm delivery in the US has risen by nearly 20% since 1990 (1). Apart from medically indicated preterm delivery (~ 20% of preterm deliveries), the underlying cause is unclear (2-3). Among the traditional risk factors, the strongest is a prior history of preterm delivery. Another is race/ethnicity-preterm delivery that is 60% higher among African American women and 40% higher among Puerto Rican Hispanics (4). Differences in risk factors explain the ethnic disparity in preterm delivery to a very limited extent. Data on genetic polymorphisms suggest that genetic factors are not a major contributor to the disparity (5). Inflammation involves an elevation in cytokine levels and affects disease progression and prognosis; the inflammatory cytokines are higher among ethnic minorities (6-8). Many factors influence the inflammatory response and some are driven by modifiable factors like diet (9-11). Circulating free fatty acids (FFAs) are correlated to fat intake, and alter inflammation by inducing or suppression cytokine production. Whether FFAs-mediated inflammation influences the course and outcome of pregnancy and affects the ethnic disparity independent of known risk factors has not been studied. Using extant data and specimens from a large prospective cohort (N=2816, enrolled 1996-2006, Hispanic 44.5%, African American 38.1%, Whites 17.4%), we propose to examine (i) if low-grade inflammation is an independent contributor to the ethnic disparity in preterm delivery and preeclampsia (ii) if such inflammation is altered by circulating free fatty acids which are markers for dietary fat intake. The specific aims and hypotheses to be tested are: Aim 1: To confirm that circulating FFAs are markers of dietary fat/FAs intake and to identify whether maternal circulating FFAs and individual FFAs alter the inflammatory response. A number of inflammatory cytokines will be measured from blood samples collected at entry to prenatal care (week 15) and 3rd trimester. New technology (Luminex xMAP based technology platform) that simultaneously measures multiple inflammatory markers will be used. Selected biomarkers of inflammation include TNF-α, IL-1, IL-8, C- reactive protein (CRP), fibrinogen, soluble TNF-receptors 1 and 2, IL-6 and adiponectin. Plasma FFAs concentrations and FFAs composition will be measured by enzymatic assay and GCMS. Hypothesis: Inflammatory cytokine levels are altered by circulating FFAs. Polyunsaturated FFAs especially omega-3 FFAs reduce and saturated FFAs increase the inflammatory response. To confirm that circulating FFAs are good markers of dietary fat/FAs intake in our population, we will also test the correlation between plasma FFAs and composition with dietary fat/FAs intake using three 24h dietary recalls of the maternal diet during pregnancy. Positive correlations are expected based on published and pilot data. Aim 2: To determine whether there are ethnic differences in maternal inflammatory cytokine levels. We will compare the concentration of each cytokine by ethnicity at entry and 3rd trimester. Hypothesis: There are ethnic differences in the markers of inflammation (MOI). African American and Puerto Rican Hispanic women have elevated levels of the MOI compared to White women. Aim 3: To examine if ethnic differences in inflammation give rise to ethnic differences in preterm delivery and preeclampsia. The primary outcome is preterm delivery (delivered <37 weeks) and the secondary outcome is preeclampsia, both of which are related to the inflammatory process. Continuous and categorical variables will be used to define high or low level of the MOI and tested for each outcome/complication by ethnicity. Known risk factors, e.g., age, parity, smoking, underweight (preterm) and obesity (preeclampsia) will be controlled for. Hypothesis: Elevated inflammatory cytokine levels are associated with preterm delivery and preeclampsia. Ethnic differences in inflammation are present, placing African Americans and Puerto Rican Hispanics at increased risk of preterm delivery and preeclampsia. The unique aspects of this proposal are (i) There are no prior epidemiological studies examining the contribution of circulating FFAs-mediated inflammation to ethnic disparities in pregnancy, particularly preterm delivery. (ii) Plasma FFAs are good markers of dietary fat/FAs intake and can easily be modified by a different selection of food or by supplementation; such modification in diet can reduce ethnic disparities in pregnancy outcome/complications. (iii) We will use a rich database (with over 1800 variables per subject) obtained prospectively from a high risk population of young, low income minority women. The resources to conduct the study are readily available and can be utilized in a very cost-effective manner. (iv) We also include a series of preliminary data from Camden that support our hypotheses.